DECREASED GROWTH VELOCITY/CHILDREN WITH PEDIATRIC MALIGNANCIES

To identify and evaluate patients with linear growth failure after being successfully treated for neoplastic diseases. Patiens will be evaluated for endocrine and non-endocrine abnormalities. Frequency of each abnormality will be established.